Enrichment Program

PROJECT SUMMARY: ENRICHMENT PROGRAM
The overall objective of the Enrichment Program is to enhance the C-SiG environment by promoting
education and fostering research synergy through communication amongst its members. To do this, we
pursue five complementary SPECIFIC AIMS to: i) Support an infrastructure of electronic communication
including internal and external C-SiG Web sites and a weekly email newsletter of C-SiG announcements and
relevant seminars; ii) Conduct a monthly Center-wide seminar series, 3 monthly mechanistic research
theme seminar series (i.e. intracellular signaling, cellular networks, genetics and epigenetics), and 6 regular
journal clubs; iii) Organize an annual scientific Minisymposium and an annual workshop topical to the
center mechanistic themes; iv) Facilitate extramural collaboration and technology transfer by leveraging
expertise at other institutions, including other NIDDK-funded DDRCCs via a Mini-Sabbatical Program; and v)
Nurture junior investigators by supporting an annual research career development retreat, an Early
Career Development and Research Training Program, and the newly developed Computational Biology
educational resources; vi) Integrate Pilot and Feasibility awardees and other junior faculty in leadership
roles (e.g. speaker selection and hosting, moderating, etc.). In addition, the Enrichment Program will continue
to plan and organize one annual conference every 5 years for the Midwest DDRCC Alliance (Mayo, Case
Western University, University of Chicago, University of Cincinnati, and Washington University). C-SiG has
been awarded an R13 grant to partially support the next conference, which we will host in Rochester, MN on
Oct 26-28, 2023.